GENE TRANSFER FOR THERAPY OF IL 2 RECEPTOR GAMMA CHAINDEFICIENT X LINKED SCIDI

Defects in the gamma chain gene of the IL-2 receptor (IL2RG) cause X- linked severe combined immunodeficiency (XSCID). The only current lifesaving treatment is bone marrow transplantation, but drawbacks of this include the lack of HLA matched related donors, poor post- transplant B cell function and graft vs. host disease. An in vivo growth advantage for cells with intact IL2RG makes XSCID a promising disease for retroviral gene therapy delivered to autologous bone marrow stem cells. We have made and compared different retroviruses for titer and gamma chain expression and derived two acceptable constructs for preclinical and clinical studies. Longterm expression of transduced human gamma chain protein was achieved in a dog model. Normal humans treated with cytokines mobilize hematopoietic stem cells, which are usually rare and poorly able to accept a retrovirus. We are treating XSCID patients with the cytokine G-CSF to test whether mobilization of stem cells will occur. The stem cells are currently being used for research to define the best gene transfer conditions. Once optimal gene transfer conditions are devised and clinical grade vectors are made and approved, gene therapy trials will be planned in XSCID patients who have responded suboptimally to conventional bone marrow transplantation therapy. - Gene Therapy, Genetics, Clinical Research, Pediatric Research, Immunology, Infectious Diseases, Bone Marrow, Stem Cell Research - Human Subjects